Can a novel telemedicine tool reduce disparities related to the identification of preschool children with autism?

PROJECT SUMMARY
Families seeking evaluation for autism spectrum disorder (ASD) often face barriers such as low availability of
specialists, lengthy waitlists, and long distances to tertiary care diagnostic centers. This is especially true for
children from traditionally underserved groups and communities. Without innovative approaches for enhanced
identification of ASD, families and clinicians will continue to struggle with accessing and providing care.
Telemedicine offers tremendous potential for addressing this need, but there are few psychometrically sound,
validated tools that can be administered remotely, via telehealth platforms, in order to guide service and action.
Our team developed and conducted a preliminary evaluation of a novel parent-administered, clinician-guided
tele-diagnostic tool, the TAP (TELE-ASD-PEDS), designed specifically for direct-to-home and community clinic
use with toddlers. Remote administration of the TAP yielded a very high level of agreement with blinded
comprehensive evaluation regarding ASD risk classification. Subsequently, the unanticipated broad
dissemination of the TAP during COVID-19 demonstrated its value for traditionally underserved groups, spanning
broad geographies. Although promising, this work was limited by its specific focus on toddlers with ASD
concerns. A telemedicine tool designed for the unique context and population of preschool-aged children
referred for diagnostic assessment could have tremendous value in terms of both accurate identification as well
as family engagement with service. In the current work, we propose a computationally informed co-production
in which we involve our targeted population as active partners in designing a new telemedicine tool, the TAP–
Preschool, for ASD risk assessment in preschoolers. This approach will follow our innovative methodology for
fusing advanced computational analyses with stakeholder expertise (1) by mining our large clinical registry to
identify key ASD behavior targets and (2) rigorously translating these key behaviors to generate telehealth
assessment techniques. With input from our computational experts, clinical scientists, and end-users, we will
then evaluate the performance, usability, and utility of the TAP–Preschool. We will gather critical data not only
regarding its structure and accuracy, but also its potential deployment across systems responsible for engaging
children and families from underserved groups in meaningful service. This work has potential to transform the
ASD evaluation process and dramatically improve care access for traditionally underserved groups.

Public health relevance
PROJECT NARRATIVE Families seeking evaluation for autism spectrum disorder (ASD) often face barriers such as low availability of specialists, lengthy waitlists, and long distances to tertiary care diagnostic centers and this is especially true for children from traditionally underserved groups and communities. The current project develops and tests a novel tele-assessment instrument (TAP-Preschool) designed to help overcome these barriers for children not identified or engaged by current early detection and intervention systems. This method has potential to improve access to care, eliminate the time lag between ASD symptom emergence and diagnosis, and reduce disparities for under-served populations.